Administrative Core

ABSTRACT
The overall objective of the Roswell Park-University of Chicago Ovarian Cancer SPORE Administration Core is to provide leadership, direction, scientific and fiscal oversight, and administrative services for the purposes of enhancing research productivity and maintaining a stimulating research environment conducive to translational research in ovarian cancer. Importantly, the Administration Core will catalyze, oversee, and support interactions amongst SPORE components, external and internal collaborators, other SPOREs, patient advocates, and the National Cancer Institute (NCI). In order to achieve the overall objective of managing SPORE resources and maintaining high quality in all components, the Administration Core will be organized into four main operational areas, the provision of 1) Leadership; 2) Administrative Management; 3) Clinical Trials, Data, and Communications Management; and 4) Scientific Management. This management and support are accomplished through an organizational framework that takes advantage of highly experienced leadership that is integrated within Roswell Park Comprehensive Cancer Center and the University of Chicago Comprehensive Cancer Center, an oversight executive committee for planning and evaluation of activities, and scientific and patient advocate advisors. The functions performed by the Administration Core will provide greater integration and efficiency across the program and will result in lower operating costs for each individual Roswell Park-University of Chicago Ovarian Cancer SPORE component.

Public health relevance
NARRATIVE The Administration Core will serve the Roswell Park-University of Chicago Ovarian Cancer SPORE’s overall translational research objectives by providing effective leadership and administrative support for a broad range of SPORE-related activities to ensure optimal progress and performance of all leaders, investigators, projects, cores, and developmental programs. The Core’s responsibilities include direct support to investigators; planning, coordination, and management of all scientific and administrative collaborations with the NCI, other SPOREs, and partner institutions; and facilitating interactions and collaborations with the patient advocate community.